Pyroptosis is a Trial-by-Fire Program

TITLE
Pyroptosis is a Programmed Trial-by-Fire.
PROJECT ABSTRACT
The inflammatory cell death program pyroptosis occurs in a wide range of cell types and plays important roles
in development, tissue injury, and tumor growth. Curiously, unlike other cell death mechanisms, cells frequently
survive pyroptosis activation. The persistence of a family of “inefficient” cell death genes is puzzling and suggests
they may have other roles. Intuitively, cells that survive the inflammatory insult will dictate both the short-term
adaptation and long-term repair and regeneration afterwards. Therefore, a flawed death program may actually
be a “trial”. However, the details of cell survival after pyroptosis and the biochemical circuitry beyond its activation
are under-studied, hindering our basic understanding. In this Program, we hypothesize that cell death is a side-
effect of pyroptosis, which in fact aims to reprogram cell functions. To explore the new concept that “trial-by-fire”
provides strong evolutionary advantages, we will investigate 1) whether it is possible to stop/resume pyroptosis
and the basic mechanisms used to exert such control; 2) the capacity and limits of pyroptosis signaling; and 3)
the single cell phenotypic effects of weathering pyroptosis. In pursuing this central hypothesis, we will discover
new cell signaling circuits and simultaneously enhance the field’s ability to detect novel pathways by developing
new genetically encoded tools, imaging algorithms, and bioinformatics methods. The Program aims to construct
a new perspective that the salient function of pyroptosis is to prime and educate through a near-death experience.
The proposed administrative supplement combines sound platforms like Fluorescence Assisted Cell Sorting
with new technical developments in protein engineering to boost the scale and speed at which accurate data on
pyroptosis signaling can be generated.

Public health relevance
PROJECT NARRATIVE Evolution tends to improve or remove a gene that is bad at what it does. A gene that nominally causes cell death often fails to kill cells; yet it is still found across many organisms and actively utilized. Perhaps we mis-understood its true, underlying functions? We refocus its role as a “trial-by-fire” and outline the novel tools and methods we will use to examine the evolutionary benefits that allowed this gene family to thrive and diversify.